Bioinformatics Shared Resource

The mission of the Bioinformatics Shared Resource (BIOINF) is to provide state-of-art bioinformatics expertise
for the design, analysis, and interpretation of genomics, proteomics, and other high-resolution, high-throughput
studies for better understanding of cancer biology, thereby facilitating translation of cancer omics discoveries to
cancer treatment. The BIOINF ensures that CCSG investigators have ready access to expert bioinformatics
support and services to carry out basic science, translational, clinical, and population-oriented research.
BIOINF served a total of 122 Roswell users, of which 90 (74%) were CCSG members. The BIOINF has
provided critical value-added bioinformatics services to CCSG programs as evidenced by co-authoring 150
peer-review manuscripts, and serving as co-investigators and/or bioinformaticians on 47 extramural grants.
Electronic computational and storage space is a large component in bioinformatics data collection and
analysis. The BIOINF takes advantage of two locally available computing resources necessary to provide
high-level bioinformatics support. First, through collaboration with the Roswell Park IT department, we have
maintained a high-performance cluster with 1,600 processors and 600 TB of high-performance storage.
Second, through a formal collaboration with the Center for Computational Research (CCR) at UB, we have
ready access to the Linux cluster with more than 8,000 processor cores and 3 PB of high-performance storage.
The Specific Aims of the BIOINF: 1) To collaborate with project investigators by providing methodologic and
analytic expertise including study design and conduct, development and implementation of data analytic plans,
and interpretation of analysis results; 2) To develop and disseminate innovative open-source bioinformatics
software packages; 3) To provide bioinformatics education and training to the cancer center community. The
goal of the BIOINF is to continuously supply rigorous and efficient bioinformatics solutions necessary to
address the clinical, translational and basic science questions of the investigators we support. Future efforts
will focus on developing novel bioinformatics tools to handle emerging and diverse high-throughput data and
collaborating with BDS to initiate a joint quarterly educational program for Roswell Park investigators on
understanding and using data science to strengthen their research.